Enhancing the public health benefits of mammography screening by informing women of both breast cancer and breast arterial calcification results: A randomized trial to promote cardiovascular health

Breast mammography is one of the most successful cancer screening tools in the cancer prevention arsenal. 37 million women in the US will receive a mammogram this year, and following that, these women will receive a letter letting them know whether they do or do not have evidence of breast cancer. Recent research indicates that standard digital mammography also yields additional information critical to women’s health; that is, information about the presence of calcifications within breast arteries - breast arterial calcification (BAC). The presence of BAC has been associated with calcification within coronary arteries, which is a marker of coronary artery disease (CAD). Research indicates that at least 12.7% of women’s mammograms reveal BAC – about 1 in 8. Of those with BAC, 32%-96% have CAD. Thus, conservatively, mammography could detect over 1.5 million cases of CAD each year. Despite this potential public health boon, BAC information is not directly communicated to patients in the post-mammography letter. The failure to communicate BAC status is a missed opportunity to inform women about CAD risk, and is inconsistent with patient preferences. The goal of this proposal is to investigate whether provision of BAC information to women post-mammography influences their cardiovascular health behaviors. We will randomize mammography patients whose imaging reveals BAC (N=1,889, English and Spanish-speaking) to either: a) the BAC-Enhanced letter condition which informs women about their positive BAC findings and the BAC-CAD association, encourages women to seek preventive cardiology care, and provides cardiology referral information; or b) the Waitlist Control condition, where patients receive a standard mammography letter initially and learn their BAC status 6 months later. We hypothesize that women who receive the BAC-Enhanced letter will be more likely to attend a cardiovascular health appointment (primary outcome), engage in heart healthy behavior, and have CAD detected. Guided by the Common Sense Model, we seek to understand which psychological factors mediate the relationship between the intervention and the outcomes. Also, most BAC prevalence literature has been conducted on predominantly white samples. To remedy this, we will describe BAC prevalence in a large, racially and ethnically diverse sample (N=14,875). Innovation: This will be the first study of an intervention to directly share BAC information with women undergoing mammography in a “direct to consumer” approach, and the first to report BAC prevalence in a racially and ethnically diverse sample. Public health impact: The project is a first step towards ensuring that women benefit directly from all of the rich health data that mammography can yield.

Public health relevance
PROJECT NARRATIVE Mammograms can serve a dual function - screening for breast cancer and looking for evidence of cardiovascular disease (breast arterial calcification, BAC) – without additional radiation to the patient, without increasing mammography appointment length, and adding only minimally to breast radiologist time. Reporting BAC directly to patients as part of standard mammography practice could uniquely promote prevention, diagnosis, and treatment of cardiovascular disease in women, which is the main cause of death among women in the United States. The primary goals of this study are to investigate the effects of informing patients about their BAC results (versus a Waitlist Control) on their cardiovascular health behaviors (attending a cardiovascular appointment, improving heart healthy behavior) and on their likelihood of receiving a diagnosis of coronary artery disease.